Administrative Core

The Administrative Core will oversee the entire MGH/Harvard AADCRC program, manage the day-to-day Center activities and direct the multi-disciplinary collaborative research activities. This Core will be responsible for administering the overall budgets of the Projects and Cores, finalizing contractual arrangements and ensuring that the aims of each project are being met. The Administrative Core will also be responsible for ensuring the Human Subjects Core, the Tetramer Core, and Bioinformatics Core are used fairly. The Administrative Core will be directly involved with managing, coordinating and overseeing the administrative functions related to the complex protocol process and safety procedures for the projects and cores. The Administrative Core will facilitate collaboration between the projects and cores by organizing mandatory monthly meetings for all personnel associated with the Center. The Administrative Core will also coordinate and support the invitation of two outside speakers per year whose research is directly related to the Center. The Core will effectively and regularly communicate with all PI/PD's, project and core staff, and administrators.

Public health relevance
The Administrative Core is essential in ensuring project coordination and measurement of the quality control of the ongoing research.